Use of sentiment analysis in SMS and social media to understand HIV prevention needs among young women in Kenya

Project Summary. The impact of effective HIV prevention tools depends on their use by people when they are
at risk for HIV; however, many individuals are uncertain about their HIV prevention needs. Currently used risk
scores and criteria (e.g., the VOICE HIV risk score for young women in sub-Saharan Africa) have been
developed and validated in various populations, only to perform poorly when implemented more broadly. Novel
approaches to assessment of HIV prevention needs are needed. Sentiment analysis involves natural language
processing, text analysis, and computational linguistics to systematically identify, extract, quantify, and study
affective states and subjective information. This technique has been successfully applied to understand various
types of human behavior but has not previously been applied to HIV risk in Africa. This R21 application
proposes to develop a sentiment analysis tool to assess HIV prevention needs based on SMS and/or social
media messages among young women in Kenya. Importantly, participants in the recently completed Monitoring
PrEP Among Young Adult women (MPYA) trial in Kenya found providing WhatsApp messages for sentiment
analysis to be acceptable, and preliminary data are promising for identification of HIV risk. Because a smart
phone app can process SMS and/or social media data for sentiment analysis in 10 minutes, this type of tool
has great potential for use in routine care. Key next step questions include the type and amount of social
media data needed for optimal correlation with HIV status and the best means to ethically and practically
integrate this tool in routine clinics. We hypothesize sentiment analysis will provide novel insights into HIV
prevention needs that may ultimately be shown to predict HIV incidence. We propose the following aims:
1. Explore ethical factors that may influence sentiment analysis of SMS and/or social media messages
through individual qualitative interviews with 32 young women (16 who would and 16 who would not
provide SMS/social media data) and a focus group discussion among five Kenyan bioethicists.
2. Conduct topic modeling and network analysis of SMS and/or social media messages (e.g., WhatsApp,
Instagram, Twitter) to predict HIV prevention needs among 400 young women (age 18-24) seeking HIV
testing, PrEP, and other sexual and reproductive health services in Kisumu, Kenya. We will use
automated structural topic modelling to determine “topics” (i.e., word clusters) and assess for
association with other risk assessments (e.g., VOICE score) as the primary outcome and HIV test
results as an exploratory outcome. Data collection and analysis will conform to Aim 1 findings.
3. Assess practical factors that may influence use of a sentiment analysis tool in routine care through a
needs assessment with focus group discussions of 20 clinical staff and 10 young women from Aim 2.
This study will yield an optimized sentiment analysis tool for assessing HIV prevention needs that is tailored for
clinic implementation and ready for large-scale testing on HIV incidence in a future R01-funded trial.

Public health relevance
Project Narrative The impact of effective HIV prevention tools is limited because many people do not know that they are at risk for HIV acquisition, despite the availability of various risk assessment scores and criteria. This proposal aims to use a novel data science approach to assessing HIV prevention needs among 400 young women in Kisumu, Kenya— namely, topic modeling and network analysis of text and/or social media messages (e.g., WhatsApp, Instagram, Twitter). The study will involve in-depth assessment of relevant ethical and logistical factors to ensure appropriate and optimized use of a sentiment analysis tool for implementation in routine clinical care.